Molecular and clinical evaluation of the glioma patient experience to anticipate modern outcomes and guide patient care

Project Summary
Landmark papers published recently by us, and others, mark the new era of molecular diagnoses and precision
therapy for glioma. In the summer of 2016, the World Health Organization (WHO) published updated diagnosis
criteria for glioma that include molecular markers, taking a first step toward a molecularly precise diagnosis. It is
our long-term goal to capitalize on the longitudinal resources of brain tumor banks to rapidly assess molecular
hypotheses for prognosis and treatment of glioma. With the significant contribution of 240 cases from Henry Ford
Hospital (HFH), an effort to molecularly and clinically profile glioma was started by The Cancer Genome Atlas
(TCGA) project. Capitalizing on our clinically annotated brain tumor bank at HFH, we will focus on therapeutic
outcomes, recurrent disease, and extended survival, which were not captured in the TCGA project. For this work,
we have constructed an interdisciplinary team of collaborators, with clinical and informatics expertise, to profile
an additional 340 glioma cases (WHO grade II-IV). In total, we will assess 700 tumor specimens (FFPE/frozen)
from the HFH tumor bank (2001-present), representing both primary and matched progressive disease (Aim 1).
Molecular data will be generated by exome sequencing to assess DNA sequence and copy number variants,
targeted Sanger sequencing to profile the TERT promoter, and DNA methylation array assays to profile the
methylome. Clinical annotation from our tumor bank, including long-term follow-up and therapy regimens, will be
added to each of the 550 profiled glioma cases. The resulting comprehensively-annotated tumor bank will be an
invaluable resource for queries of clinical-molecular associations and the progression of disease, made available
to researchers at HFH and beyond. In this proposal we use our database to address two analytical aims: (Aim
2) to carefully design statistical models of prognosis and therapy response among modern diagnosis classes
using retrospective records; (Aim 3) to identify genomic differences, per patient, arising over the course of
treatment and progression, which we expect will impact therapy decisions and inform standard treatments
strategies. As part of the third aim, we will also explore the genomic patterns and clinical response of patients
with exceptional survival, which may indicate differential molecular diagnosis or suggest therapeutic avenues for
extending survival in others.

Public health relevance
Project Narrative/Relevance Statement Glioma diagnosis guidelines now rely on tumor DNA changes more than on how the tissue looks under a microscope. We expect that the new guidelines will improve care, but we must wait to observe modern outcomes. To support clinical decisions now, we use banked glioma tissue and thorough clinical records to create statistical models to predict therapy response and overall survival under the new diagnosis guidelines.